Core-007

Creating a Learning Health System (LHS) that overcomes the artificial barriers between clinical care and
research will require significant learning and change. We have developed extensive, world recognized
expertise and capacity in health system transformation and have demonstrated that a network organizational
model to create LHSs works at scale. Our objective is to develop and test interventions that facilitate the
emergence of two pilot LHSs within our Academic Health Center (AHC). We will pursue two specific aims to: 1)
engage stakeholders in co-designing and collaboratively testing interventions to facilitate emergence of LHSs
that improve outcomes by integrating clinical/translational research with health care practice; and 2) develop a
collaborative laboratory to further advance best practices for instantiating the networked organization by
aligning and integrating functions across existing Center for Clinical and Translational Science and Training
(CCTST) Cores. As a result of the proposed effort, we expect to have a replicable, tested approach to
facilitating the emergence of LHSs within the AHC, as well as workforce, scientific, and informatics
infrastructure to enable the CCTST to function as a learning system to pursue this work at the AHC and across
the CTSA network. This is significant because it will further advance knowledge for how to accelerate the
translation of research into improved outcomes and lead to better care and health for our region and the
nation.